Neonatal and Young Pediatric Kidney Preservation through Nanowarming and Vitrification

ABSTRACT
The kidney transplant waitlist comprises 83% of the U.S. organ transplant waitlist- yet, for every 5 waitlist patients
who die, or become too sick for transplantation, 3 potentially transplantable kidneys are discarded. Infants and small
children on the waitlist have a higher organ discard rate than adults due to locality and timeframe constraints.
Extending and improving kidney preservation would enable nationwide (eventually global) donor-recipient matching
for these young children and also allowing additional good quality kidneys not transplanted today to be offered to
older patients. Long duration kidney preservation can also enable translation of clinical immune tolerance induction
avoiding life-long immunosuppression. Using effective cryoprotective agents (CPAs) our team and others have
successfully cryopreserved tissues in an ice-free vitreous “glassy” state, allowing for indefinite storage. Unfortunately,
these advances had not been matched by similar advances to prevent damage from ice growth and/or fracturing
during rewarming. Recently, our co-PIs Dr. Finger and Dr. Bischof demonstrated a scalable and biocompatible
nanowarming technology using radiofrequency (RF)-excited iron oxide nanoparticles (IONPs) for ice and fracture
avoidance during rewarming from cryogenic storage. The nanowarming technology led to the successful completion
of our Phase I study resulting in: 1) optimized CPA selection, permeation, and critical cooling and warming rates
for kidney slices, and 2) established vitrification and nanowarming for whole rat and, beyond the initial Phase I
scope, rabbit kidneys. Subsequently, Dr. Bischof’s team has demonstrated the world’s first and only, successful,
repeat transplants of mammalian kidneys after cryogenic preservation. Building on this unprecedented
achievement and the Phase I feasibility success, we here scale-up and apply this new technology to neonatal
and pediatric kidney preservation, where the physics of heat transfer make it exponentially less challenging to
cryopreserve smaller (younger) organs compared to adult organs. Our goal will be achieved via 3 Aims: 1)
vitrification and nanowarming of whole juvenile porcine model kidney with i) optimization of pediatric size
kidney vitrification protocols as well as ii) identification of potential mechanism(s) of any remaining injury, 2)
optimization of vitrification cocktails and perfusion protocols for neonate, infant, and small children human
kidneys, with (i) biocompatible cryostasis cocktails and (ii) effective revival/reconditioning protocols for enhanced
reperfusion, 3) orthotopic survival autotransplantation with long-term survival, with the best protocols from SA
1-2 and compared via current ex vivo clinical assessment practices ahead of proof of concept for 100+ days
storage and transplantation in juvenile pigs, and human decedent recipients. Altogether, this constitutes an
important standalone project enabling further breakthroughs in biopreservation, tissue engineering, biomedical
research, and clinical practice. This will set the stage for our logistical model of centralized centers of excellence
for preservation and assessment, enabling vastly improved clinical outcomes and patients’ access globally.

Public health relevance
NARRATIVE Every year, thousands of potentially transplantable kidneys are not used and for every 5 waitlist patients who die, or become too sick for transplantation, 3 kidneys are discarded. Organ preservation would address organ shortage by (a) enabling clinical immune tolerance induction, (b) greatly expanding options for donor-recipient matching and equitable allocation, (c) enhancing screening for transmissible diseases and malignancies, (d) decreasing costs and enabling flexible scheduling of surgeries, and (e) allowing for organ quality assessment and reconditioning. Infants and small children in need of a transplant have an especially hard time finding a suitable donor nearby and during the specific time period, resulting in a higher organ discard rate than adults. Serendipitously, the physics of heat transfer make it exponentially easier to cryopreserve smaller pediatric vs. larger adult organs. Our team have recently demonstrated the world’s first and only, successful, repeat transplants after ice-free cryogenic preservation of mammalian kidneys using the nanowarming technology. Building on the project’s Phase I feasibility success, in this Phase II project, we will apply our combined expertise in nanowarming, organ machine perfusion and organ transplant to young pediatric size kidneys in a juvenile pig model and human pediatric kidneys.